Transcriptional adaptation and sensory function in the olfactory system

Abstract
Adaptation is fundamental to the function of all sensory systems. In the olfactory system, the olfactory sensory
neurons (OSNs) that detect odors undergo a form of rapid adaptation that evolves over milliseconds to
seconds, is mediated by post-translational mechanisms, and is thought to reshape responses to highly
dynamic odor plumes. In addition, central neurons adapt to odors on timescales of minutes, which is thought to
help distinguish salient cues from background. However, it is not yet clear how olfactory sensory neurons
adapt at the longer timescales over which animals traverse different environments — and therefore encounter
different background stimuli — as is common during a typical circadian cycle. We have recently developed
single cell sequencing (scSeq) data that demonstrate that every OSN subtype (as identified by its OR)
expresses a distinguishable transcriptome. We show that transcriptional variation among OSNs is
systematically organized through a bidirectional, rheostat-like mechanism (akin to a balance control on a
stereo) whose setting in each OSN is defined by OR-environment interactions. This transcriptional rheostat is
composed of more than 70 genes relevant to OSN function, whose expression levels vary continuously across
OSNs in an OR-dependent manner. Because activity patterns in each OSN reflect the combined influence of
its OR and the environment, the position of the rheostat is different in each OSN subtype, and dynamically
varies as mice traverse distinct environments. Critically, we also show that the specific position adopted by this
rheostat (i.e., the OR-specific pattern of functional gene expression) predicts the odor response amplitude of a
given OSN (as assessed by a transcriptional metric called the activation score). Thus, rather than faithfully
reporting the extent of odor-OR interactions, the peripheral olfactory system dynamically uses gene expression
to instantiate expectation, thereby building odor codes that are continuously personalized (over hours-long
timescales) by each animal’s experience. Here we propose several Aims to further characterize the
relationship between experience-dependent transcriptional adaptation and olfactory function. In Aim 1 we will
combine scSeq, Act-Seq, functional imaging and spatial transcriptomics to ask how OSN-specific ES scores
relate to acute odor-driven glomerular responses. We will also assess how faithfully odor-driven activation
scores relate to acute odor responses as assessed by functional imaging, which will further validate Act-Seq as
a powerful method for odor receptor deorphanization. In Aim 2 we will characterize the signaling and
transcriptional mechanisms that couple OSN activity to long-term expression patterns for functional genes and
changes in neural odor codes. Finally, in Aim 3 we will ask whether environment-dependent changes in
peripheral odor codes impact odor perception and behavior. Together these Aims will reveal how odors are
translated into adaptive patterns of gene expression, and how these patterns in turn influence odor processing;
addressing the questions posed by these Aims is essential for a full account of olfactory system function.

Public health relevance
Narrative All of our senses can separate predictable background signals (like pervasive food odors in a kitchen) from critical cues that demand action (like the smell of smoke from a pan that is on fire); we propose experiments to better understand how the olfactory system performs this critical task of distinguishing expected odors in the background from more salient cues.